Engineering Tissue Level Targeting of Biologic Drugs via Automated Interfacial Microneedle Pumps

Project Summary/Abstract:
Biologic drugs have transformed the treatments of a variety of diseases, including diabetes, cancer, and heart
disease. However, their large size prevents them from easily diffusing into targeted tissues when administered
orally or via subcutaneous injection. For example, gastrointestinal mucosal tissue, myocardial muscle tissue and
solid tumor tissue are so densely packed that macromolecules can barely penetrate hundreds of micrometers
into the tissue from an implanted drug depot or leaky blood vessel. This prevents drugs, such as cytokines that
have been demonstrated to promote wound healing in models of myocardial infarction, from reaching the
impacted tissue areas where they could provide therapeutic effects. Even though local administration of drugs
is becoming increasingly necessary to provide therapeutic efficacy, no research or tools exist on understanding
the flow of fluid into tissue. Instead, healthcare professionals inject drugs manually with varying flow rates and
pressures, leading to inconsistent care and potentially devastating consequences. Delivering too much drug too
quickly may dislodge cancer cells in a solid tumor, promoting their circulation and generation of additional
metastases. It may also cause drug to leak out of the solid tumor, generating systemic uptake and off-target
effects. Delivering too slowly, on the other hand, may generate a depot profile where the distance between the
drug and the impacted tissue is greater than the length that the drug can readily diffuse. This proposal will focus
on developing an injection system for healthcare professionals to perform standardized and automated internal
tissue injections. Injecting at flow rates optimized to the mechanical and physiological properties of the tissue
will allow for greater drug distributions while preventing the off-target side effects and tissue damage generated
from overpowered injections. Success of this proposal will yield (1) a computational model capable of predicting
drug distributions in heart and solid tumor tissue at various injection characteristics as well as (2) a clinically
translatable injection system that optimizes and standardizes injections of wound healing drugs and
immunotherapies into these tissues, respectively.

Public health relevance
Project Narrative Biologic drugs have transformed the treatments of a variety of diseases, including diabetes, cancer, and heart disease, but they require injection into the body since these molecules are too large to easily diffuse through the tissue walls. Even though local administration of drugs is becoming increasingly necessary to provide therapeutic efficacy, no research or tools exist on understanding the flow of fluid into tissue. In this proposal, we will develop a computational model capable of predicting macromolecule drug distributions in tissue following an injection and a clinically translatable injection system that optimizes and standardizes injections into heart and tumor tissue.